Mechanisms governing myosin turnover and exchange in vivo.

ABSTRACT
Striated muscle myosin is highly organized into thick filaments that bear the molecular forces generated by the
myosin heads. While thick filament structure and stability are essential for contractility, the mechanisms that
allow fully developed muscles to replace myosin molecules while maintaining contractile fidelity are unclear.
Critical questions include; what are the temporal dynamics of myosin synthesis and degradation (i.e. turnover)
and how are molecules selected for degradation? Do striated myosin molecules exist in a dynamic equilibrium
with thick filaments to allow for their exchange out of and into thick filaments? If thick filament structure is
dynamic, what are the molecular mechanisms governing this equilibrium? Most importantly, is this mechanism
tunable to modify striated muscle structure and/or function? We will address these questions in an adult mouse
model in three aims. Our overall hypothesis is that myosin turnover is a stochastic process which involves the
exchange of individual myosin molecules between a cytosolic pool of monomers and thick filaments, by a
mechanism governed by the folding of the monomers within the cytosol. Aim 1 will define the turnover rate of
cardiac myosin in our model and determine whether myosin degradation occurs via a stochastic (i.e. random)
mechanism by using a combination of isotope labeling strategies and mass spectrometry. Aim 2 will test the
hypothesis that the organization of striated muscle myosin is highly dynamic to allow for the rapid exchange of
individual molecules between thick filaments and a cytosolic pool of monomers by virally labeling myosin with a
fluorescent tag in vivo and examining the mobility of the myosin within hearts using multiphoton fluorescence
recovery after photobleaching. Aim 3 will test the hypotheses that the structural conformation (i.e. folded vs.
extended) of individual myosin molecules in the cytosol regulates the exchange of myosin molecules between
pools. Aim 3 will take advantage of a drug that folds myosin and reduces cardiac mass. We will test our overall
hypothesis that tuning myosin folding, affects the effective concentration of myosin with the cytosol, and
regulates its availability for degradation. The proposed studies will be the first to examine myosin turnover and
macromolecular exchange in a striated muscle system in any intact animal model. The results will provide
conceptual innovation that fully developed muscle is designed in such a way to allow for structural
rearrangement of myosin on a minute-to-minute timescale. The mechanistic findings have the potential to add
to the current paradigm regarding thick filament structure and explain how striated muscle is maintained from
the single molecule to whole organ level. The new knowledge gained may allow us to take advantage of this
mechanism for tuning striated muscle structure and/or function in whole animals.

Public health relevance
PROJECT NARRATIVE Striated muscle myosin molecules are highly organized within exquisite force generating macromolecular complexes, but myosin molecules must somehow be replaced while continually supporting muscle contractility. Our preliminary data demonstrate that the organization of myosin is highly dynamic and rearranges on a minute-to-minute timescale in intact muscle. This project will establish the mechanisms that regulate the dynamic rearrangement of myosin in muscle and provide insight into how we can tune these mechanisms to alter muscle structure.